Low-Dose Magneto-Thrombolysis to Expand Stroke Care

Acute ischemic stroke (AIS) results from a blood clot in the neurovasculature and is a leading cause of death
and neurological disability in the United States (US). AIS impacts more than 700,000 Americans annually, with
a 65% chance of death or severe disability. By 2030, it is expected that the AIS economic burden will exceed
$180B in the US alone.
Standard AIS therapies include FDA-approved thrombolysis using alteplase (i.e., tissue plasminogen
activator, tPA) within 4.5 hours of stroke onset and earliest-possible thrombectomy for large vessel occlusions
(out to 24hrs). In contrast to thrombectomy, thrombolysis does not require confirmation of a vessel occlusion.
Because only ~10% of AIS victims are eligible for thrombectomy, thrombolysis remains a critical first line tool to
treat those diagnosed with AIS. When employed, thrombolysis is associated with a modest ~15% improvement
in stroke outcomes, resulting in only ~10% fully recovering. However, due to alteplase's ~7% dose-dependent
hemorrhage risk, thrombolysis remains contraindicated for mild and wake-up strokes which together make up
~60% of all AIS events. Currently, thrombolysis usage within the US remains low (~10%) with 90% of all AIS
victims only receiving palliative care. Thus, there is an urgent need to improve the efficacy and safety of
thrombolysis and extend thrombolysis to more AIS victims.
UNandUP has invented a novel nanoparticle-based thrombolysis platform to safely accelerate alteplase to
AIS-associated blood clots, thereby overcoming restrictive hemodynamics known to prevent alteplase from
reaching the occlusion. The platform overcomes this barrier by 1) conveying alteplase-conjugated magnetic
nanoparticles to the clot’s surface more than 350X faster than normal biological diffusion (so that lysis starts
within minutes versus hours), and 2) mechanically mixing alteplase at the clot’s surface to improve lysis using
an alteplase dose nearly 250X lower than currently approved (which promises to eliminate alteplase’s elevated
hemorrhage risk). C3i participation and FDA/regulatory meetings confirm a likely CDER pathway which,
although lengthier and more costly than a CDRH pathway, results in a commercially attractive pharmaceutical
product. The platform is affordable to hospitals, does not require precise knowledge of the clot’s location, and
is intended to support EMT transfers between spoke and hub stroke centers, thereby ensuring thrombectomy
is not delayed. Once proven safe and effective, UNandUP’s goal is to extend the benefits of thrombolysis to
nearly all 700,000 AIS victims, which is 10X more than currently treated. By leveraging UNandUP’s prior
success in developing magnetic nanoparticles and portable magnet systems, the aims of this effort can focus
on synthesizing cGMP nanoparticles using proprietary magnetic cores and conducting safety and efficacy
studies in support of an FDA-CDER regulatory approval process.

Public health relevance
There are more than 700,000 annual acute ischemic stroke (AIS) events in the US which result in nearly 150,000 deaths, making AIS the fifth leading cause of death and the leading cause of neurological disability. Although thrombectomy is the standard of care for those diagnosed with a treatable large vessel occlusion in the anterior circulation, improvements in thrombolysis are needed given that most AIS events are not amenable to thrombectomy. UNandUP (short for “Unmet Needs and Underserved Populations”) has invented a safe and effective nanoparticle-based magnetic thrombolysis platform which can be applied to nearly all AIS victims.